Practitioner-level determinants of dental service use by Medicaid beneficiaries

PROJECT SUMMARY
Children insured through Medicaid, in comparison to privately-insured children, suffer from higher rates and
more severe oral health problems, but are less likely to use dental services. Florida has one of the lowest
percentages of dental use among Medicaid children, given the number of dental practitioners who accept
Medicaid coverage. To address this problem, previous research has examined system-level factors that
influence access to dental care, such as reimbursement rates and dental practitioner density. However, limited
research has examined patient- and practitioner-level mechanisms that contribute to lower use of dental
service use in this population (e.g., the relationship between the patient and the practitioner affect use of health
services based on the health-care practitioners’ beliefs and attitudes, interpersonal communication style,
acceptance of different types of insurance). To test a multilevel model of healthcare use, this study will use a
mixed-methods research design to characterize the perceptions of both dental care practitioners and low-
income caregivers of children with Medicaid dental coverage in Florida. This research design and focus on
both patient- and practitioner-level factors will provide a more granular investigation of core determinants of
dental service use among an underserved population from two important perspectives. I will evaluate
constructs related to perceptions, attitudes, and cognitive beliefs of low-income caregivers and dental
practitioners in Florida through sequential qualitative and quantitative data analyses, including perceived lack
of access to dental practitioner who accepts new Medicaid patients, attitudes toward the dental care
practitioner or low-income caregiver, and beliefs about the importance of the patient-practitioner relationship. I
predict that both groups will identify converging and diverging determinants of low dental service use among
children with Medicaid coverage. Results will lay the foundation for research on barriers and facilitators
identified in a nationally representative sample and ultimately the development of a multi-perspective
intervention targeting practitioner-level factors.

Public health relevance
PROJECT NARRATIVE Disproportionately high severity and prevalence of oral health problems and low use of dental services are seen among children with Medicaid dental coverage. The project described in this application will use a mixed- methods research design to characterize the perspective of dental practitioners and the perspective of low- income caregiver of children with Medicaid dental coverage in Florida.